MALDI-TOF at Oregon Veterinary Diagnostic Laboratory (OVDL)

Project Summary/Abstract
Mass spectroscopy/matrix-assisted laser desorption/ionization-time of flight (MS MALDI-TOF)
systems are now a standard method of bacterial pathogen identification and characterization
available at many veterinary diagnostic laboratories. However, the Oregon Veterinary Diagnostic
laboratory (OVDL) lacks such a system. OVLD receives a widely varied diagnostic caseload with
pathogens from common domestic animals but also wildlife, aquatic and marine species of the
Pacific Northwest and the OVDL services are vital to a variety of clients and public health.
Traditional bacteriologic diagnostic methods are well-established at the OVDL but a MS-MALDI
TOF system would allow more rapid and sometimes accurate information and also
supplement/validate traditional methods. The OVDL has in place facilities and intellectual
resources to handle a MS-MALDI TOF system. A MS-MALDI TOF system would complement
our current methods and allow the OVDL to be fully operational for Vet LIRN projects.

Public health relevance
Project Narrative Mass spectroscopy/matrix-assisted laser desorption/ionization-time of flight (MS MALDI-TOF) technology is increasingly vital to identification of pathogens and essential for the Oregon Veterinary Diagnostic Laboratory (OVDL) which currently lacks such a system. A MALDI would be useful for molecular diagnostic, bacteriology and parasitology laboratories.